Modeling Cerebral Microbleeds and Striatal Brain Iron in Adult Congenital Heart Disease in Relationship to Differential Genetic Risk for Alzheimer Disease

Emerging data suggests that the soaring population of adult survivors of congenital heart disease (CHD),
are at increased risk of developing cognitive decline and early-onset dementia. The role of other important risk
factors for dementia, including the presence of cerebral microbleed, elevated brain iron levels, and
apolipoprotein E (APOE) genotype in adult CHD is unknown. With an allele frequency of 14%, APOE-ε4 is
present in approximately 25% of the US population and associated with increased risk of Alzheimer’s Disease.
Our overall hypothesis the presence of cerebral microbleeds and elevated brain iron levels predict poor
neurocognitive outcomes and accelerating presenile (early onset) dementia risk in adult CHD and that this
relationship is moderated by APOE genotype. In the current ancillary Ro1 to the NHLBI-funded Pediatric Heart
Network (PHN) MINDS study, we are measuring acquired brain injury and multi-modal neuroimaging biomarkers
leveraging the neurocognitive testing of the patient cohort between 18-30 years of age and utilizing the well-
established infrastructure already in place for the parent PHN MINDS study. There is limited research about the
long-term impact of CHD on these relevant neuroimaging biomarkers [cerebral microbleeds measures with
susceptibility weighted imaging (SWI) and striatal brain iron measured with resting functional imaging (BOLD)]
that have been developed in detail utilizing large-scale dementia risk populations (Alzheimer’s Disease
Neuroimaging Initiatives- ADNI). Our preliminary data in adult CHD MINDS patients demonstrate findings that
overlap with Alzheimer’s disease which includes a high prevalence (>50%) of young adult CHD patients with
cortical and subcortical microbleeds as identified with SWI imaging. The goal of this administrative
supplement is to expand the delineation of neuroimaging biomarkers to deeply characterized features
of these cerebral microbleeds (using quantitative SWI) and rigorously quantitate striatal brain iron (using
resting BOLD imaging). The MINDS parent study also includes an extensive NIH-Tool Box
neurocognitive/neurobehavioral testing battery. We will eventually be able to leverage the extensive parent
MINDS study biological specimen collection/analysis which includes not only DNA, but also ApoE genotyping
data and other vascular stress and resilience genotypes. Our specific aims for this administrative
supplement are: Specific Aim #1: Cerebral Microbleeds: Quantitate multi-dimensional features of cerebral
microbleeds using SWI imaging. Advanced neuroinformatic techniques will be employed including spatial
morphometry and machine learning techniques. We will correlate features of cerebral microbleeds with
neurocognitive outcomes (primary), cardiovascular related patient/medical factors data (secondary), future ApoE
genotyping (exploratory). Specific Aim #2: Striatal Brain Iron Measurement: Leverage the current MINDS
neuroimaging protocol to quantitate striatal brain iron using resting state BOLD imaging. Correlation with features
of cerebral microbleeds, neurocognitive outcomes and future ApoE genotype in the MINDS cohort will also be
performed. The results from our proposed administrative supplement to our current Ro1 grant will help to
elucidate the way interactions between cerebral microbleeds, striatal brain iron and APOE genotyping
abnormalities give rise to cognitive-behavioral phenotypes by leveraging the NHLBI-funded PHN MINDS study.
By delineating and identifying which adult CHD patients are mostly likely at risk for cognitive decline/dementia at
the earlier time point possible will allow us to employ prevention of modifiable risk factors. Reciprocally, the
results from our proposed administrative supplement will help inform the relationship between APOE ε4 genotype
expression and cerebral microbleeds and striatal brain iron which may precede overt cognitive impairment in
Alzheimer disease by several decades. Early detection of these brain alterations holds inherent value for not
only prognostication, but also the development and evaluation of preventive treatment therapies for not only
CHD- related dementia, but also Alzheimer disease, possibly employed during the young adult period.

Public health relevance
Adult CHD (ACHD) now outnumber children with CHD. ACHD patients demonstrate domain-specific neurocognitive deficits and reduced quality of life, including lower educational attainment and less social interaction. The mechanism of neurocognitive impairment in the ACHD population is unknown and few neuroimaging studies in this population exist. We propose an administrative supplement to this multi-modal neuroimaging ancillary study to the NHLBI-funded Pediatric Heart Network (PHN) “Multi-Institutional Neurocognitive Discovery Study” (MINDS) in Adult Congenital Heart Disease (ACHD) to deeply characterize cerebral microbleeds and quantitative striatal brain iron concentration and correlate these multi-modal neuroimaging biomarkers to neurocognitive outcome, clinical risk factors and APOE genotype. We will also determine if the associations between cerebral microbleed and striatal brain iron concentration and neurocognitive outcomes in ACHD patients are modified by behavioral and environmental enrichment proxies of cognitive reserve, using traditional statistical models and machine learning techniques. By delineating and identifying which adult CHD patients are mostly likely at risk for cognitive decline/dementia at the earlier time point possible will allow us to employ prevention of modifiable risk factors. Reciprocally, the results from our proposed administrative supplement will help inform the relationship between APOE ε4 genotype expression and cerebral microbleeds and striatal brain iron which may precede overt cognitive impairment in Alzheimer disease by several decades. Early detection of these brain alterations holds inherent value for not only prognostication, but also the development and evaluation of preventive treatment therapies for not only CHD- related dementia, but also Alzheimer disease, possibly employed during the young adult period.